Development of Asymmetric Cooperative Gold Catalysis and Beyond

Cooperative catalysis or catalysis involving metal-ligand cooperation is a highly versatile approach in
catalysis that have resulted in a myriad of highly efficient synthetic methods and conferred exceptional value to
chemical synthesis of bioactive and/or pharmaceutical compounds. Despite extraordinary advances on this
research topic, there are still much need to develop new cooperative systems based on unique ligand designs to
enable the development of new and/or much improved synthetic methods for chemical synthesis.
In 2014, the PI initiated a program on the development of bifunctional biaryl-2-ylphosphine ligands that are
designed to enable cooperative gold(I) catalysis. These ligands feature remote basic groups that can engage
bonding interactions with substrates or reagents during catalysis and thereby achieve ligand-metal cooperation.
Several preliminary studies, including a ppm-level gold-catalyzed addition of carboxylic acid to alkyne, an
asymmetric isomerization of alkyne into allene, and trapping of catalytically generated σ-allenylgold
intermediate with aldehyde, have validated the ligand design and the cooperative nature of the catalysis.
As the major focus of the PI’s future effort, this proposal seeks to apply this cooperative gold(I) catalysis
strategy to the development of asymmetric transformations of exceptional synthetic values. These include
expedient construction of chiral butenolids and 2,5-disubstituted pyrrolines and asymmetric propargylation
reactions/propargylic C-H functionalizations. The extension of this strategy to much cheaper cooperative Cu(I)
and Ag(I) catalysis offers new and distinct opportunities in asymmetric enolate protonation, which would open
valuable access to various carbonyl products. The transition to functionalized N,N-bidentate ligands would
enable the application of the cooperative ligand design concept to a much broader range of metal catalysis and
offer unprecedented opportunities to manipulate carbonyl compounds in asymmetric manners.
This proposal, if implemented, would introduce a range of new and versatile chiral bifunctional ligands to
metal catalysis and inspire increasing research effort in cooperative catalysis. Moreover, the methods developed
would provide efficient access to a variety of chiral structures of high value to chemical synthesis in general and
pharmaceutical R&D in particular.

Public health relevance
Project Narrative: Novel and highly efficient synthetic methods developed in this proposal could be applied in and/or facilitate the preparation of bioactive compounds either as small molecular probes for elucidating medically relevant biological pathways or as drug candidates for disease management.